DNAzymes for Site-Specific DNA and RNA Nucleobase Modification

Project Summary
This Focused Technology Research and Development proposal addresses the urgent need for new tools to
perform in vitro site-specific modification of DNA and RNA nucleobases of long nucleic acid substrates. The
biochemistry, biophysics, and biology of DNA and RNA are heavily influenced by particular nucleobase
modifications. However, studies of these modifications are often limited by the ability to synthesize the modified
nucleic acids. Therefore, innovative new technologies are required to circumvent the limitations of the existing
chemical and enzymatic modification approaches.
DNAzymes (deoxyribozymes) are artificial DNA sequences with enzymatic function, analogous to protein
enzymes as catalytic sequences of amino acids. Although DNAzymes are unknown in nature, they can be
identified de novo in the laboratory by starting with random DNA sequence pools and performing in vitro selection
for the desired enzymatic activity. DNAzymes are operationally simple to obtain and use: they are readily
prepared commercially by solid-phase synthesis, and they easily modify their substrates in simple aqueous
incubation conditions with standard buffers and salts. DNAzymes have been identified for a growing range of
catalytic activities, but most applications of DNAzymes are limited to the two long-known reactions of RNA
cleavage and hemin-dependent peroxidation, which are unrelated to DNA and RNA nucleobase modification.
In the proposed studies, DNAzymes will be identified for a qualitatitvely new approach to site-specific in vitro
modification of DNA and RNA nucleobases, by either N-acylation or (via reductive amination) N-alkylation at N4
of cytosine, N2 of guanine, and N6 of adenine. Rather than relying on natural protein enzymes, either as found
in nature or evolved by directed evolution, entirely new DNAzymes whose sequences are unconstrained by
natural evolutionary history will be identified by in vitro selection.
Three specific aims are proposed. In Aim 1, in vitro selection will be used to identify DNAzymes for N-
acylation of C, G, and A nucleobase amines in DNA and RNA substrates. In parallel Aim 2, in vitro selection will
be used to identify DNAzymes for N-alkylation by reductive amination of C, G, and A nucleobase amines in DNA
and RNA substrates. In both of these aims, the electrophilic reaction partner will be either an oligonucleotide or
a small molecule, as a tunably fluorinated aryl ester for the acyl donor in Aim 1, and as an aromatic or aliphatic
aldehyde, or activated imine variant thereof, for the reductive amination partner in Aim 2. In Aim 3, the DNAzymes
from Aims 1 and 2 will be characterized with regard to their substrate sequence scope and refined by reselection
for improved function, to facilitate practical use as an innovative new technology for site-specific DNA and RNA
nucleobase modification.
By the conclusion of the proposed efforts, we will have established DNAzymes as an important new
technology for in vitro site-specific DNA and RNA nucleobase modification by N-acylation and N-alkylation.

Public health relevance
Project Narrative DNA and RNA nucleobase modifications are relevant for fundamental biochemical and biophysical experiments and are widespread throughout biology. DNAzymes are catalytic DNA sequences, analogous to protein enzymes as catalytic amino acid sequences, that unlike protein enzymes can be identified from initially random DNA sequence populations by in vitro selection. The proposed Focused Technology Research and Development seeks new DNAzymes for in vitro site-specific acylation and alkylation of the nucleobase amino groups of cytosine, guanine, and adenine, which will enable a range of biochemical, biophysical, and biological experiments involving site-specifically modified DNA and RNA nucleotides.